HEALTH LOCUS OF CONTROL AND COMPLIANCE TO DIABETIC REGIMEN

The purpose of this study was designed to determine the correlation of health locus of control on overall glucose control of Type I and Type Ii diabetes-dependent individuals.